Adipose Dysfunction, Imaging, Physiology, and Outcomes with SGLT2i's for Sleep Apnea: The ADIPOSA Study

Project Summary
Lack of effective, well-tolerated treatments for obstructive sleep apnea (OSA) has impeded research examining
the impact of treatment on health outcomes, and it represents a serious lost clinical opportunity to reduce
morbidity and mortality related to OSA. Metabolic modulation may be a prime target to prevent and treat OSA.
One promising, newly identified pathway requiring further exploration is how pharmacologic sodium glucose
co-transporter 2 inhibition (SGLT2i) may impact OSA. The overall goal of this project is to conduct a 2-center
mechanistic clinical trial of N=164 overweight or obese adults (BMI 25-40 kg/m2) diagnosed with moderate to
severe OSA (with and without T2D) randomized to ertugliflozin 15 mg once daily vs. placebo for 6 months to
evaluate the impact of SGLT2i on anatomic, non-anatomic physiologic, and clinical traits of OSA. We will
accomplish this by the following three separate specific aims:
Specific Aim1: Measure the effects of SGLT2i on anatomic OSA traits. Hypothesis 1: SGLT2i will ¯ visceral
and neck fat, ­ airway caliber, ¯ upper airsoft tissue structure volumes, and ¯ Pcrit/Vpass. Sub-aim 1: Explore
the effects SGLT2i on plasma biomarkers of dysfunctional adiposity.
Specific Aim 2: Quantify the effects of SGLT2i on non-anatomic, physiologic OSA traits. Hypothesis 2: SGLT2i
will ¯ LG and ¯ rostral-caudal fluid shifts. Sub-aim 2: Explore the effects SGLT2i on ArTh and Mresp.
Specific Aim 3: Investigate the effects of SGLT2i on clinical outcomes of OSA severity and sleep deficiency.
Hypothesis 3: SGLT2i will improve clinical measures of OSA severity (e.g., AHI) and sleep deficiency. Sub-aim
3: Perform formal mediation analysis to assess whether the effects of SGLT2i on OSA severity and sleep
deficiency clinical outcomes is mediated through individual anatomic and non-anatomic physiologic traits and
markers of dysfunctional adiposity.
For all aims, analyses will account for age, sex as a biological variable, race/ethnicity, obesity class, type 2
diabetes status, and CPAP use. The integrated findings of these aims will create a unique opportunity for a well
powered, mechanistic trial to definitively elucidate the mechanisms of the SGLT2i-OSA relationship. This
knowledge has the potential to yield new insights for pharmacologic therapeutic targets for OSA, determine
which OSA patient phenotypes may be most responsive to SGLT2i, and provide preliminary data for definitive,
prospective phase 3 trials to test the efficacy of pharmacologic SGLT2i on OSA prevention and treatment.

Public health relevance
Project Narrative This study is relevant to public health because it will help researchers design studies of targeted approaches to treatment of obstructive sleep apnea and obesity. The findings will guide the development of future drugs and devices for obstructive sleep apnea. Such results will have a positive impact on future diagnostics and interventions, and permit select interventions early on in the progression of all three disorders, thereby reducing cost and preventing adverse cardiovascular outcomes.